Munc13-4 Regulates Peptide Hormone Degradation in Neuroendocrine Cells

PROJECT SUMMARY
Peptide hormone biosynthesis in the RER, packaging into secretory granules (SGs) in the Golgi, and exocytosis
of SGs at the plasma membrane are well-studied processes in neuroendocrine cells. However, there is limited
understanding of intracellular peptide hormone degradation and SG turnover. Only a small fraction (<10%) of
SG-stored peptide hormones are utilized in physiological stimulation so that most SGs would undergo turnover.
SG degradation mechanisms need to be balanced by SG biogenesis to maintain SG pools it is unclear how this
coordination is achieved. Classical EM studies in the pituitary and endocrine pancreas had shown that SGs
merge with multivesicular body (MVB)/lysosomes for degradation in a process termed crinophagy. We developed
several fluorescence-based cell assays in neuroendocrine BON cells to detect the SG-MVB/lysosome merge.
Because Munc13-4 is involved in endosomal fusion mechanisms in multiple cell types, we conducted the assays
in cells knocked down for Munc13-4 and observed strong inhibition. In aim 1, we will extend structured
illumination microsope studies to resolve whether crinophagy is the major mechanism and whether it is
accompanied by microautophagy. We will pursue CgA timer protein studies to document that older SGs are
preferentially degraded and determine whether such SGs are marked by ubiquitination. Lastly, by reconstituting
SG-MVB/lysosome merge in a cell-free assay, we will determine whether Munc13-4 acts directly to promote the
SG-MVB/lysosome merge. In efforts to document that Munc13-4 knockdown should mimic lysosome inhibitor
treatment, we revealed that Munc13-4 knockdown has additional effects likely upstream from SG degradation.
Instead of SG accumulation, we observed that SGs were smaller. When examined carefully, the small SGs were
observed to undergo constitutive exocytosis. This implies that Munc13-4 also has effects on the SG biogenesis
pathway. Follow-up studies will include immunofluorescense studies of marker proteins to determine where small
SGs emerged in Munc13-4 knockdown cells. The overall phenotype of Munc13-4 knockdown is dominated by a
shift from SG degradation to constitutive exocytosis. Were this to be true for hormones or prohormones this
would have physiological consequences that we will assess in a Munc13-4 KO mouse. In aim 2, we will determine
the mechanistic basis for the Munc13-4 regulation of the SG-MVB/lysosome merge. An siRNA screen using a
robust fluorescence-based assay for the SG-MVB/lysosome merge, we will identify Rab, SNARE, and accessory
factors required for SG-MVB fusion. We will develop a liposome-based fusion assay using the proteins identified
in the screen. This will allow us to test what factors like Rab27 regulate Munc13-4-dependent fusion. Lastly, with
highly purified Munc13-4 protein we will determine its structure by cryo-EM. Based on a on a liposome fusion
assay, we will determine the tethering properties of Munc13-4 in cryo-ET studies. Overall this work will reveal
important new cellular roles for Munc13-4 in neuroendocrine cells and contribute a molecular understanding on
the tethering role for Munc13-4.

Public health relevance
PROJECT NARRATIVE Peptide hormones are signaling molecules that are packaged into secretory granules for secretion into the bloodstream by endocrine cells. Intracellular degradation of peptide hormones occurs when secretory granules merge with degradative organelles called lysosomes. This work will analyze a tethering factor called Munc13-4 that directs the merge of secretory granules with lysosomes, which will be relevant for understanding lysosomal storage diseases such as mucolipidosis type IV.